Role of NOTCH2 in Articular Inflammation

PROJECT SUMMARY/ABSTRACT
Osteoarthritis is a chronic inflammatory and degenerative disease of the joint affecting the cartilage,
synovium and subchondral bone. Notch signal activation has been associated with the development of
osteoarthritis, and inactivation of its canonical signaling prevents the osteoarthritis that follows destabilization
of the medial meniscus (DMM). These findings indicate a role of Notch in the pathogenesis of osteoarthritis.
However, the mechanisms responsible are not understood. We created a mouse model harboring a moderate
gain-of-NOTCH2 function mutation and termed Notch2tm1.1Ecan. Notch2tm1.1Ecan mice are sensitized to the
development of osteoarthritis following DMM surgeries, and chondrocytes from mutant mice are sensitized to
the actions of tumor necrosis factor α (TNFα) and interleukin 1β (IL1β). The induction of interleukin (IL)6 and
IL1β by TNFα and IL1β is amplified significantly in Notch2tm1.1Ecan chondrocytes, an effect that is independent of
canonical signaling indicating the existence of novel signaling pathways operating in osteoarthritis. Our findings
demonstrate a new role for Notch in the inflammatory response and osteoarthritis, but the cell and mechanisms
responsible are not known. To explore the consequences of the NOTCH2 gain-of-function in specific articular
cells, we created a Notch2 conditional by inversion (COIN) mouse model. The goal of our research is to
establish the cell and mechanisms responsible for osteoarthritis and the enhanced inflammatory response to
NOTCH2. Our specific aims are: Aim 1. To define the cell responsible for the NOTCH2-dependent
osteoarthritis. To this end, we will utilize a conditional Notch2 mouse model to induce the NOTCH2 gain-of-
function in specific articular cells; Aim 2. To establish the mechanisms responsible for NOTCH2 dependent
osteoarthritis by defining transcriptome profiles and pathways responsible for osteoarthritis in the context of a
NOTCH2 gain-of-function; and Aim 3. To establish the mechanisms responsible for NOTCH2-dependent
inflammation by defining signaling pathways influenced by NOTCH2 to enhance the inflammatory response.
The overarching goal of the proposed work is to discover novel mechanisms of Notch signaling operational
in osteoarthritis and interrogate undiscovered Notch-related pathways and mechanisms responsible for an
enhanced inflammatory response to Notch in cartilage.

Public health relevance
PROJECT NARRATIVE These investigations will provide information on novel mechanisms responsible for osteoarthritis. The proposed work will serve to establish the function of an important cellular receptor that plays a role in the pathogenesis of inflammation and osteoarthritis. This may lead to novel therapies targeting the receptor as a means to treat or prevent osteoarthritis.